Virally-induced tumorigenesis controlled by the microbiota

Abstract
All multicellular organisms are colonized with a diverse and complex population of microbes including
bacteria, viruses, fungi, archaea, and protozoans, collectively called the microbiota. Microbiota play an integral
role in modulating host health by providing necessary nutrients, by protecting against incoming bacterial
pathogens and by supporting the development and maturation of the immune system. Microbiota could also
impact cancer development at various stages by modulating cell proliferation and death, altering the function of
the immune system, and influencing metabolism of various compounds.
Murine Leukemia Virus (MuLV) is highly proficient in causing leukemia in mice from susceptible strains.
Using MuLV, we found that some gut commensal bacteria promoted the development of leukemia induced by
this retrovirus. The promotion of leukemia development by commensal bacteria was due to suppression of the
adaptive immune response through upregulation of several negative regulators of immunity. These negative
regulators included serine (or cysteine) peptidase inhibitor, clade B, member 9b (Serpinb9b) and Ring finger
protein 128 (Rnf128). Serpinb9b is known to counteract killing by cytotoxic granzymes and was upregulated in
leukemic cells. Rnf128 known for induction of unresponsiveness of T cells was induced uniquely in CD4 T
cells. Genetic ablation of these genes conferred resistance to virally-induced leukemia even in the presence of
a complex microbiota. Upregulation of Serpinb9b was mediated via the RIPK2 pathway (downstream of NOD1
and NOD2 receptors which detect various forms of peptidoglycan).
As Serpinb9b and Rnf128 are associated with a poor prognosis of some spontaneous human cancers,
the mechanism of bacterially-induced immunosuppression during tumor development may apply to human
tumors of virally and non-viral origin. The current proposal aims at defining the precise mechanism(s) by which
microbially-induced negative immune regulators contribute to leukemia progression. Specifically, we will
identify the innate immune receptors bacterial products signal through to induce negative immune regulators
and determine the adoptive mechanism which controls leukemia development in the absence of bacteria.

Public health relevance
Project Narrative We have shown that the gut commensal bacteria promote the development of virally-induced leukemia through suppression of the adaptive immune response. Suppression was mediated by the upregulation of negative immune regulators known to be poor prognostic factors in some human cancers, such as Rnf128 and Serpinb9b. This proposal will define the mechanism by which the commensal bacteria confer ability to tumors to evade immune attack.